Fathers and Children Exercising Together (FACEiT)

Brief Summary
There are three main objectives of the protocol: 1) to develop a family-based PA promotion intervention in
which fathers are the participating parent. 2) to determine if a family-based PA promotion intervention in which
fathers are the participating parent will be feasible to delver, and 3) to obtain preliminary evidence of efficacy.
The intervention will be developed through a qualitative research process in with African American fathers to
determine essential elements of the program and to assist in adapting the intervention. Three study groups are
planned: a standard intervention, a community enhanced intervention, and an active control group. Feasibility
will be determined by comparing recruitment, retention, attendance, and satisfaction to pre-determined
thresholds. The secondary outcomes include daily step counts as measured by the Actigraph accelerometer,
anthropometrics, father reported involvement and self-efficacy, child perceived support and parenting skills,
and father reported dietary intake. These measures are key because they will determine the feasibility and
preliminary effectiveness of an intervention where African American fathers are the participating parent.

Public health relevance
Narrative African American children engage in low amounts of activity, placing them at risk for health disparities as they age. African American fathers may be instrumental in helping to promote physical activity in their children. The current proposal is designed to use community-engaged research methods to develop a physical activity intervention for children in which their fathers are the agents of change, and to determine the feasibility of implementing this intervention.